Targeting cancer cachexia drivers using antibody-based approaches

PROJECT SUMMARY
Cancer-associated cachexia is a debilitated syndrome that has a dramatic impact on the quality of life and
outcome of patients. Cancer cachexia occurs with a remarkably high incidence in pancreatic ductal
adenocarcinoma (PDAC) patients. Cancer cachexia is characterized by the progressive depletion of muscle
skeletal mass, which often culminates in general organ dysfunction and patient death. Therefore, a deeper
understanding of the underlying mechanisms of cancer cachexia would ultimately lead to the identification of
innovative therapeutics to improve the management of muscle wasting in cancer patients.
Our recent studies have shown that pancreas-specific ablation of the Tgif1 gene in a KrasG12D background
led to a dramatic acceleration of PDAC in mice. Quite intriguingly, despite having this severe PDAC phenotype,
these mice do not display any prominent sign of cancer cachexia, such as progressive weight loss and decreased
muscle mass and function. This contrasts with our previous study using two different mouse models of human
PDAC, KPC (KrasG12D and heterozygous deletion of Trp53) and KICLuc (KrasG12D and homozygous deletion of
p16Ink4a), which consistently manifest severe cancer cachexia during PDAC progression. These findings hint
at the possibility that TGIF1 might function in PDAC cells to initiate events that culminate in muscle cachexia. In
efforts to probe this possibility, we generated a new mouse model that allows for conditional overexpression of
Tgif1, and found that enforcing TGIF1 expression in the pancreatic epithelium was sufficient to induce muscle
cachexia. Subsequent mechanistic experiments revealed an ability of TGIF1 to induce expression of FN14,
which functions as a transmembrane receptor in cancer cells to drive inflammation leading to muscle cachexia.
Enforced TGIF1 expression also induced the expression of the membrane-bound form of transforming growth
factor alpha (TGFa), whose overexpression in the pancreas also drives an inflammatory phenotype similar to
what we observed in mice with conditional overexpression of TGIF1. Inspired by these intriguing findings, we
created a new bispecific antibody (Bis-14a) to simultaneously neutralize the pro-cachectic activities of FN14 and
TGFa. This tremendous progress prompted us to design a variety of innovative genetic and antibody-based
pharmacological approaches to provide irrefutable proof-of-principle that targeting FN14 and TGFa downstream
of TGIF1 could offer innovative therapeutic strategies to curb cancer cachexia. Overarching specific aims are:
Specific Aim 1: Expand role and translational potential of TGIF1 in PDAC-driven muscle cachexia
Specific Aim 2) Explore the mechanisms by which TGIF1 facilitates PDAC-driven muscle cachexia
Specific Aim 3) Test the therapeutic efficacy of monoclonal and bispecific antibodies targeting
FN14 and TGFa signaling in PDAC-mediated muscle cachexia
As such, completion of this highly innovative proposal will likely culminate in a paradigm shift in our
understanding and treatment of this lethal wasting syndrome.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer-mediated muscle cachexia is a severe wasting syndrome that occurs in virtually every patient and strongly predicts poor outcome. How pancreatic cancer drives muscle cachexia is still unfolding. Upon completion, this study will shed new insights into mechanistic paradigms of muscle cachexia and hopefully thereby pave the way for therapeutic breakthroughs to curb this life-threatening condition.